Regulatory genomics of T cells in mouse and human

Project Summary/Abstract
T cells coordinate systemic immunity and are essential for defense against viral and bacterial infections and tu-
mors. The long-term goal of our research program is to employ innovative experimental genomics to build multi-
dimensional data resources and develop new computational methods that we will use to obtain a comprehensive
understanding at a molecular level of T cell activation and differentiation in response to various stimuli. We will
address speciﬁc problems about T cell commitment to functional fates across contexts, regulatory mechanisms
of these processes and their underlying transcription factors. Unprecedented resolution and statistical power will
allow us to study similarities and differences of these mechanisms between T cell lineages and subpopulations,
and generalizability of these observations from mouse to human. This goal will be achieved by executing three
projects. We will study regulation of T cell activation and functional commitment in lymphocytic choriomeningi-
tis virus (LCMV) infection model with a focus on the progenitor TCF1+ T cells (Project 1), transcriptional and
epigenetic regulation and higher order chromatin organization in Treg cells (Project 2). Finally, we will build a
database, methods, software and interfaces for comparative analysis of regulatory genomics data across mouse
models and humans, allowing many fundamental and translational applications (Project 3). These studies will
lead to future research and development of new therapeutic transcription factor and other targets and modulation
strategies in diseases of dysregulated T cell immunity. Our data resources and methods will enable systematic
data exploration, generation and validation of new speciﬁc hypotheses about molecular mechanisms of T cell
function, and will provide a platform for mapping and analyzing new T cell data from new systems that we and
others will generate in the future.

Public health relevance
Project Narrative T cells coordinate systemic immunity and are essential for defense against pathogens. Systematic molecular analysis of T cells and of T cell interactions with other cell types across tissues is fundamentally important for better understanding of mechanisms of the adaptive immune system and critical for developing better T cell modulation therapies for infectious diseases and autoimmunity. The goal of our research program is to employ innovative experimental genomics to build multi-dimensional data resources and develop new computational algo- rithms that we will use to obtain a comprehensive molecular understanding of T cell activation and differentiation in response to various stimuli across biological contexts in mouse and human.